The role of Tie2 signaling in Aortic Valve Remodeling

Abnormal valve development contributes to many common congenital heart malformations.
Developmental signaling events that regulate early valve formation have been studied extensively, however,
the mechanisms that underlie latter stages of remodeling to mature valves remain poorly understood. We have
recently identified a critical time point at the early stage of semilunar valve remodeling that is fundamental for
normal aortic valve formation and have also identified a unique endocardial signaling axis, TIE2-PI3K/AKT-
FOXO1, that plays a pivotal role in orchestrating this early remodeling process. Therefore, we propose to 1)
Delineate the unique roles of TIE2 signaling in heart valve remodeling in vivo. We will utilize our newly
developed inducible endocardial Cell (EC) specific Nfatc1CreERT2 line, pan-endocardial (Nfatc1Cre) line, and
valvular endocardial specific (Nfatc1enCre) line, to generate valvular EC-specific Tie2 conditional knockout (ko)
models. PostnMCM will likewise be used to generate valvular mesenchymal cell ko mutants.
We will
thoroughly
examine the cardiac phenotypes of these conditional mutant mice and determine the direct effectors of
endocardial TIE2 signaling in heart valve remodeling. 2) Define the role of the TIE2-PI3K/AKT-FOXO1
signaling during semilunar valve remodeling in vivo. We will generate an EC overexpression of a gain-of-
function FOXO1 mouse line (FOXO1CA). We will also generate Tie2 and FoxO1 double knock out mutants via
utilization of Nfatc1CreERT2 and Tie2 and FoxO1 floxed alleles and EC overexpression of a gain-of-function PI3K
mouse line (PIK3CAH1047R) via Nfatc1Cre and Nfatc1enCre, respectively. The resultant mutant mice will be
thoroughly analyzed to determine which components of the cardiac valve defects seen in Tie2-icko and
Nfatc1enCre;PIK3CAH1047R mutant mice are phenocopied or rescued, thus defining the specific roles of TIE2-
PI3K/AKT-FOXO1 signaling in valve formation. 3) Identify additional down-stream targets of TIE2
activation that regulate heart valve remodeling. To validate and reinforce the TIE2-FOXO1 linear pathway
proposed based on in vivo studies, we will analyze candidate gene/protein expression of cultured endothelial
cells exposed to CAng1, a potent Angpt1 variant agonist, and PI3K inhibitor (LY294002) in the presence or
absence of Tie2. In addition, we will use bulk RNAseq of cultured cells and scRNAseq of outflow tracts
harvested from control and inducible endocardial Tie2 ko embryos to identify and characterize additional TIE2-
dependent signaling pathways required for semilunar valve development. These studies will provide the first
characterization of the critical period of aortic valve remodeling immediately following EMT. This work will also
elucidate a uniqe endocardial signaling mechanism (namely, the TIE2-FOXO1 axis) that modulates
remodeling in cardiac valve formation. These studies are essential to advance our understanding of normal
cardiac valve ontogeny and will be foundational for deciphering the mechanisms of disease pathology related
to valve formation and function.

Public health relevance
Summary: We have identified a discrete stage of heart valve development that is critical for aortic valve morphogenesis and have also discovered a unique cascade of endocardial signaling proteins that are essential for normal valve formation prior to birth. Our goal is to understand how these signaling cascades within the endocardium direct normal aortic valve development. As most congenital heart defects involve abnormalities of heart valve formation, these studies will lay the foundation for understanding the etiology many congenital heart diseases.